Innovation Corps supporting BoostOne SBIR

Project Summary
Individuals with opioid use disorder (OUD) face both short-term and long-term challenges to
healthy and productive decision-making. While recovery success is deeply affected by
phasic/psychological propensity for re-use, current strategies for cravings control suffer from
limited usability and restricted utility. The proposed innovation (“BoostONE”) comprises a
proprietary software-delivered method for just-in-time management of such risk events, as a
supplement to standard medication assisted treatment for OUD. Aims include platform
refinement and a real-world feasibility study. We anticipate this Phase I SBIR will provide the
foundation for deployment of BoostONE in active treatment settings and for broader extensions
of the underlying novel technology framework.

Public health relevance
Project Narrative Opioid use disorder (OUD) and related conditions are extremely damaging to individuals and society. Cravings and impulsivity are key contributors to OUD relapse which remain underserved by current treatments/tools. We propose to address both key contributors, in parallel, under a common theoretical framework, via a novel smartphone intervention (“BoostONE”).